Designing a spatial navigation intervention protocol informed by region-specific brain activation for individuals at risk for dementia

Abstract: With no cure available yet, lifestyle interventions to slow down cognitive decline and delay onset of
Alzheimer’ disease and related dementias are essential. Up to a third of dementia cases may be preventable
by engaging in protective behaviors, such as staying cognitively active, according to observational data. Yet,
current cognitive training protocols to delay dementia onset often fall short. Here we argue that designing an
intervention informed by specific contributions of brain regions subserving cognition will yield better results.
This pilot project is focused on spatial navigation (SN), the ability to travel familiar/unfamiliar environments.
Difficulties forming new and maintaining old spatial memories is a common and early sign of Alzheimer’
disease and can lead to disorientation and dependence in daily activities. Tau and amyloid-beta accumulation
starts in regions subserving SN, such as mediotemporal and posterior parietal cortex. Even though SN
difficulties present an important target, there are few clinical trials aimed at SN. Many trials use desktop-based
SN train protocols, which deprives learners from movement-related sensory and kinematic information during
active navigation. Similarly, neuroimaging requires participants to refrain from gross motor movements. To
overcome these limits, we developed a full-immersive virtual-reality (VR) maze which participants learn to
navigate and use Mobile Brain Body Imaging (MoBI) to synchronously record body movement with EEG to
record and analyze brain activity at the source level during active movement through space. The aims of this
pilot project are to 1) determine feasibility of a VR-SN maze training protocol and 2) explore training-induced
neuroplasticity in older adults participating in VR-SN exercises. We seek to enroll 30 older adults with amnestic
mild cognitive impairment to train twice a week for 50 min over a 4-month period. VR mazes are designed to
induce different navigational strategies (allocentric and egocentric) at different periods (Stand/Encode and
Walk/Navigate) of maze learning. Allocentric and egocentric spatial strategies are known to rely on
mediotemporal and posterior parietal cortex regions, respectively. Hence, developing a VR-SN maze training
protocol and collecting source-localized milliseconds precise brain measurements during active navigation, we
enable us to identify, dissociate, and track participants’ brain dynamics applying mediotemporal-based
allocentric and posterior parietal-based egocentric navigational strategies and test relationships with
improvements in SN. Time required to navigate mazes will serve as our behavioral outcome. Region-specific
modulations in theta (3-7Hz) and alpha (8-12Hz) power will serve as our neurophysiological outcome
measures. We provide preliminary VR-MoBI maze test findings showing navigation-related theta and alpha
modulations during Stand/Encode and Walk/Navigate periods. This pilot study will position us to design a
future randomized clinical trial to test efficacy to improve navigational abilities, and thereby delay cognitive
decline in older adults at-risk for dementia.
1

Public health relevance
Narrative: This pilot project targets spatial navigation difficulties, a common and early sign of Alzheimer’s diseases, using virtual reality and light-weight neurophysiological recording methods to develop an evidence- based intervention protocol informed by specific contributions of brain regions subserving spatial navigation. We seek to enroll older adults at risk for dementia to 1) determine feasibility of the intervention protocol and 2) explore training-induced neuroplasticity. This will position us to design a future evidence-based intervention and test efficacy to improve navigational abilities, and thereby delay cognitive decline in older adults at-risk for dementia.